Cerebral Palsy Risk Identification System

PROJECT SUMMARY
Neonatologists are often required to identify infants who are likely to suffer poor neurodevelopmental
outcomes, including Cerebral Palsy (CP). CP is the most common motor disability among children in the United States
and is associated with risk factors including low weight for gestational age, premature birth, and stroke. Although MRI
and cranial ultrasound provide valuable structural information in the preterm period, they have moderate predictive
accuracy for early CP risk identification. Over the past 20 years, numerous studies have validated the clinical potential
of General Movement Assessment (GMA) for early CP risk identification and there is consensus in the literature that
GMA offers the highest accuracy. Stage 1 “cramped synchronized” general movements (CSGMs) spanning 34-48
weeks gestational age (GA) during the “writhing movements” period and Stage 2 “forced, voluntary movements”
spanning 50-59 weeks GA have demonstrated high sensitivity and specificity for developing CP, conjointly ranging
from 80%-98% when performed by extensively trained experts.
Despite its potential, GMA is available in very few clinical centers, as adoption and routine application depend
on the availability of highly trained GMA raters to perform lengthy and costly bedside observations or video review-
based scoring and manual report creation. A Cerebral Palsy Risk Identification System (CPRIS) is proposed that will
be the first to automate GMA for routine application. The CPRIS constitutes a next-generation approach that will
fundamentally transform GMA by replacing rater visual gestalts with objective, systematic, validated movement pattern
classification. Further, the CPRIS potentially offers a means of informing, and assessing the efficacy of emerging stem
cell-based interventions for CP along the early developmental continuum.
Successful implementation of Phase I&II will complete a small form factor, mobile, highly automated
preproduction system for cerebral palsy risk identification that can be readily applied by staff, clinicians, and health
care provider personnel without any form of manual post-processing operations or video file transfer. An integrated
utility will support GMA creation and report sharing with Electronic Health Record (EHR) systems. An application-
specific, fully integrated device will achieve the highest degree of standardization and thus data quality.
In a field study at two prominent Level 3 NICUs, infant movements will be acquired using an “RGB-D”, or 3D
“depth” camera in conjunction with an application- and stage-specific “Depth-Flow” convolutional neural network
(CNN) classifier approach, that requires no infant contact (contrasting with kinematic methods) and captures whole-
body movements. This effort marks the first utilization of such technology to automate GMA. Results will be compared
to consensus determinations of advanced GMA raters in a sample of high risk preterm infants at both Stages 1 & 2.
Viability of the new approach will be determined by ROC-AUC analyses, with a threshold for success of ≥ 0.90
accuracy. Overall results will be evaluated by an Advisory Committee of recognized experts in the fields of
neonatology, pediatrics, cerebral palsy, GMA and biostatistics.

Public health relevance
PROJECT NARRATIVE Cerebral palsy is the most common physical disability in childhood. The overall project goal is to develop a computerized hardware-software system capable of identifying infants at high risk of developing cerebral palsy based on the systematic identification of specific patterns of movement-derived features. The Cerebral Palsy Risk Identification System (CPRIS) will enable clinical staff with no training in General Movement Assessment to collect data sets that will then be processed by a validated machine learning classifier. The CPRIS constitutes a key enabling technology for advancement in the risk assessment of CP at the earliest possible stage along the developmental continuum.